Dissecting the cellular hierarchies of malignant gliomas by single-cell functional genomics

Summary
We believe to have made significant progress in the first 3.5 years of the funding period of
R37CA245523. We have co-led and published two research articles closely related to the original
proposal (Hara et al Cancer Cell 2021; Mathewson et al Cell 2021), with a third manuscript under
revision in a top-tier journal and two additional single-cell and spatial genomic studies in glioblastoma
nearing completion. Recent presentation of these latest works at a Keystone Conference on Single-Cell
Genomics in Cancer and Development (that I organized and chaired) attracted major interest from top
journal editors. In sum, we are excited to continue our work and advance our Specific Aims, if given the
opportunity with a two year extension period.
Project Summary/Abstract

Public health relevance
Narrative We propose to leverage a systems biology approach to dissect and target the cellular states that are driving malignant brain tumors in adults and children. We will characterize clinical samples and models by single-cell expression profiling, perform advanced computational analyses and test regulators of cell state as novel therapeutics for these incurable malignancies.